Mechanisms of endocytic recycling

SUMMARY
We are requesting an administrative supplement to the parent grant (R01GM145618) to fund a
cell-culture hood, specifically the Thermo Scientific 1300 Series Class II, Type A2 Biological
Safety Cabinet. Our current hood just broke. It cannot be repaired, because it is too old, and
thus parts are no longer available. The replacement hood that we have selected best serves
our needs while also being the most cost efficient. Cell-based studies, which require a hood for
cell culturing, are needed for all aims of the parent grant. Thus, funding of this supplement is
critical for our work.

Public health relevance
NARRATIVE Cell-based studies require the use of a biological hood to culture cells. Our hood just broke and cannot be repaired, because it is too old and thus parts are no longer available. We are applying for funds to obtain a replacement hood, because cell-based studies are critical for all aims of the parent grant.